Mitochondrial metabolism and macrophage function post MI

Abstract
Macrophages are key components of innate immunity system. It emerged recently that macrophages play critical
roles in heart health and diseases. Following myocardial infarction (MI), macrophage is recruited in high number
to the infarct site and acts as a key regulator in post-MI remodeling, generating proinflammatory signals early
and reparative cues later. However, it is not well understood how macrophage function is regulated during the
period of rapid change. Of interest, transcriptome analysis of macrophage in the infarct zone showed a time-
dependent reprogramming of mitochondrial function during the first week post-MI when macrophage phenotype
transitions from proinflammatory to reparative. This raises the question whether mitochondrial metabolism in
macrophage is causally linked to the outcome of post-MI remodeling, and if so, what the underlying mechanisms
are. Immunology research finds that macrophage activation is accompanied by global rewiring of the metabolic
pathway. Proinflammatory macrophage, elicited by Toll-like receptor ligands lipopolysaccharide (LPS), shifts it
energy metabolism from oxidative phosphorylation towards glycolysis. Such a metabolic switch is thought to
favor rapid energy production and increased demand for biosynthesis, and fuel pentose phosphate pathway for
NADPH generation, all lead to high levels of ROS and proinflammatory cytokines. On the other hand, the Th2
cytokines IL-4 and IL-13 induce alternative activation which promotes anti-inflammatory activity, wound healing
and tissue repair, and presents the opposite metabolic pattern. Although the metabolic switch has been well
described, questions remain whether differential metabolic activity (i.e., use of glycolysis versus mitochondrial
respiration) is a coincidence, a consequence of changes in phenotype, or a direct driver of macrophage function.
It is also unclear whether similar mechanisms apply to cardiac macrophages. To decipher the mechanistic role
of mitochondrial function in macrophage phenotype, we analyzed the phenotype of macrophage with impaired
mitochondrial respiration due to deletion of Ndufs4, a mitochondrial Complex I protein (KO). KO increased
glycolysis and reduced oxygen consumption in bone marrow derived macrophage (BMDM), and demonstrated
exacerbated inflammatory response to LPS stimulation. In mice with myeloid-specific deletion of Ndufs4 (mKO)
we showed increased mortality and poor cardiac function after MI. These observations led us to hypothesize that
mitochondrial function is a key regulator of macrophage polarization during post-MI remodeling and
hence a potential therapeutic target. To test the hypothesis, we will investigate the mechanistic link between
mitochondrial function and epigenetic reprogramming during stimulation in primary macrophages, and
furthermore, test the effects of manipulating mitochondrial function in macrophage function and post-MI
remodeling in mice.

Public health relevance
The proposed study will determine the metabolic mechanisms that modulate macrophage function. We will first, test the hypothesis that mitochondrial function is a key regulator of macrophage phenotype post myocardial infarction (MI) and second, evaluate the potential of targeting mitochondrial function in macrophage as a therapy for post-MI remodeling.